African Odyssey: An Integrative Genomics Analysis of Complex Physiologic Traits

DESCRIPTION Abstract One of the major challenges in the post-genomic era is understanding the complex web of genetic, developmental, physiological, and environmental interactions underlying continuous trait variation, including susceptibility to disease. Although there have been notable successes in mapping Mendelian traits, there have been relatively few successes in the dissection of the genetic architecture of complex traits involving multiple loci and environmental factors. We know even less about the genetics of complex trait variability in Africa, a region that had been under-represented in human genetics studies. Recent advances in the development of high-throughput genotyping, gene expression, and sequencing technologies now facilitate approaches that incorporate genotype and gene expression data from thousands of loci in thousands of individuals. A systems biology approach, which incorporates information about genetic interactions and transcription networks, and focuses on how naturally occurring genetic variants perturb these networks, may be more successful than traditional approaches for dissecting the genetic architecture of complex variable traits and for identifying functional variants. Equally important is understanding how these molecular networks are influenced by environmental factors including diet, lifestyle, and infectious disease status. For these reasons, I plan to use a novel integrative genomics approach, incorporating genomic, transcriptomic, and metabolomic data obtained from genetically, ethnically and geographically diverse Africans living in distinct environments. These data will provide, for the first time, a detailed knowledge of the comparative physiology of genetically and culturally diverse Africans and a detailed understanding of human evolutionary history in Africa. I will use a systems and evolutionary biology approach to identify genetic and environmental factors that influence complex physiologic traits, incl

Public health relevance
The proposed research project involves detailed characterization of genetic and phenotypic variation in ethnically and geographically diverse Africans living in distinct environments. The goal is to understand how genetic and environmental variation influences common variable physiologic traits. The main focus is studying traits that play a role in common diseases including diabetes, hypertension, obesity, and cardiovascular disease. An understanding of the genetic architecture of these traits in healthy individuals can help us to understand why some individuals, when exposed to different environments, develop disease. In addition, characterizing genetic and phenotypic variation among ethnically diverse Africans will be critically important for better understanding of differential susceptibility to disease and differential response to pharmacological agents in individuals of recent African descent and for developing more effective preventative efforts and treatments in globally diverse populations.